Administrative Core

PROJECT SUMMARY/ABSTRACT
The SASCO Administrative Core will bring together the activities of the Center under the leadership of the
MPIs with the support of experienced staff for research center administration and data management. We
supplement the Administrative Core with i) an Inclusion Lead that will monitor the Center’s Plan to Enhance
Diverse Perspectives, ii) a Leadership Team for centralized decision-making, and iii) a Resource Management
Team in charge of data sharing and model accessibility. The intra-center pilot project program will be
managed by the Leadership Team as a vehicle for welcoming junior faculty and postdoctoral fellows from
historically marginalized groups. The Administrative Core is conscientious about long-term stewardship of the
Center and has clear criteria for the External Advisory Board that it will recruit. Collectively, the Administrative
Core will facilitate communication and logistics among Center components and with the broader Cancer
Systems Biology Consortium.